ROLE OF DIALYSATE SODIUM IN CONTROL OF DIALYSIS HYPERTENSION

Effect of changes in dialysate sodium concentration on the incidence of hypertension and need for antihypertensive therapy in center hemodialysis patients.